Behavior and Neurodata Core

Project Summary
The research projects that have been supported by the COBRE Center for Central Nervous System Function
involve a wide range of complex neuroimaging and non-invasive brain stimulation methods used both
individually and in multiple combinations. These methods include, but are not limited to, structural MRI, task-
based and resting state functional MRI, diffusion imaging, transcranial magnetic stimulation, transcranial direct-
current and alternating-current stimulation, galvanic skin response, electroencephalography, and eye tracking.
The complexity of these techniques and the challenges of mastering the infrastructure required to effectively
and efficiently deploy them can significantly impede research progress, especially in the case of relatively early
stage investigators. The function of the the Phase 3 Behavior and Neurodata Core (BNC) is to provide ongoing
expert support, training, assistance and advice to the Brown researchers in the practical aspects of data
collection, data management and data processing related to these methods. The specific aims of the BNC are
(1) to continue to provide support and assistance to past COBRE Project Leaders and their research teams
and the broader research community, to promote and facilitate the acquisition of high quality research data;
and (2) to expand the areas of support to include new initiatives, including support for part fabrication, video
tracking, and behavioral task design. To meet these aims, the Core will coordinate the deployment and
maintenance of shared research infrastructure to ensure that research equipment is functional and well
documented. The Core will collect and evaluate quality assurance data to ensure that data collected are of
high quality and to identify and correct problems at an early stage. The Core will provide researcher training,
individually and in group settings, in order to promote the use of “best practices” when collecting data using a
variety of methods. It will provide expert consultation to researchers so as to guide their choices regarding the
complex and interacting acquisition parameters that must be speciﬁed for various acquisition techniques. BNC
experts will aid in deploying and supporting new analytical tools and platforms to ensure that researchers have
access to state-of-the-art methods and tools for processing their complex data sets. The BNC will create robust
data processing pipelines for the analysis of neuroscience research data that leverage the existing and
growing computational infrastructure available at Brown. The BNC will assist with data management to ensure
that large research datasets are available when needed and protected. In coordination with the Center for
Computation and Visualization, the BNC will provide training and support for the use of high-performance
computing resources. By meeting these goals, the BNC will (1) accelerate the pace of neuroscience research,
(2) establish supportive collaborative relationships among COBRE investigators throughout the local research
community based on common solutions to shared challenges, and (3) ensure the availability and accessibility
of high quality physical and computational research infrastructure to the broader brain science community.